Inflammasomes and Gasdermins in the Pathogenesis of Bullous Pemphigoid

SUMMARY/ABSTRACT Bullous pemphigoid is an autoimmune disorder characterized by the emergence of large, fluid-­filled blisters on the skin of affected patients. It is caused by pathogenic antibodies that target BP180, a component of the hemidesmosomes that attach basal keratinocytes to the basement membrane of the epidermis. The antibodies promote inflammation and neutrophil recruitment, leading to the destruction of hemidesmosomes and separation of the epidermis from the dermis. Bullous pemphigoid is the most common blistering autoimmune disorder of the skin, and 10.8% of patients in the United States die within one year of diagnosis. Even in patients successfully treated for bullous pemphigoid, recurrence is common. Thus, novel therapeutics to better treat and prevent recurrence of bullous pemphigoid are needed. Our preliminary data shows that the NLRP3 inflammasome pathway and its end product, the inflammatory cytokine IL-­1b?, are required for neutrophil recruitment and blister formation in a well-­established mouse model of bullous pemphigoid. Similarly, we observed that mice deficient in the keratinocyte-­specific protein gasdermin A had significantly lower levels of IL-­1b? within the skin and were resistant to blister formation. Gasdermin A is a member of a family of proteins that includes gasdermin D, which was recently shown to mediate IL-­1b? release and lytic cell death downstream of inflammasome activation in immune cells. Therefore, we hypothesize that gasdermin A similarly acts downstream of inflammasome activation within keratinocytes to promote inflammation of the skin and bullous pemphigoid pathology. In AIM 1, we will determine in which cell types the NLRP3 inflammasome is activated in the mouse model of bullous pemphigoid using bone marrow transplants and cell type-­specific IL-­1b? knockouts, and we will assess the role of terminal components of complement in activating NLRP3 using mice deficient in membrane attack pore formation. In AIM 2, we will compare the role and activation mechanism of gasdermin A and gasdermin D in the mouse model of bullous pemphigoid using mice deficient in gasdermin A and gasdermin D in the in vivo model of bullous pemphigoid, and by reconstituting gasdermin activation pathways in vitro. This grant is significant because it will provide foundational knowledge that may aid in the development of novel therapeutics that target inflammasomes and gasdermins to treat bullous pemphigoid. Furthermore, this grant will more broadly provide insights into the functions of keratinocytes as active participants of innate immunity and gasdermins as mediators of inflammation in the skin. Notably, to our knowledge, this would be the first in-­depth characterization of gasdermin A as a mediator of skin inflammation. Thus, insights gained from this grant may improve our understanding of the pathogenesis of bullous pemphigoid and other inflammatory conditions of the skin as well as our understanding of how the skin protects against infection.

Public health relevance
NARRATIVE Bullous pemphigoid is the most common blistering autoimmune disease of the skin. This grant will characterize the role of inflammasomes and gasdermins, including the previously uncharacterized protein gasdermin A, in promoting the development of bullous pemphigoid. Knowledge gained from this grant will provide insights into mechanisms driving inflammation within the skin and may aid in the future development of novel therapeutics to treat bullous pemphigoid.